Prevention, Preparedness, and Response (P2R) Consortium

OVERALL PROGRAM SUMMARY/ABSTRACT
The Prevention, Preparedness, and Response (P2R) Consortium is comprised of dedicated experts in
safety disciplines critical to the nation's health and well-being. Guided by a shared vision – to reduce
work-related harm and improve disaster preparedness and response – and an external advisory board of
devoted and experienced professionals, the P2R Consortium serves as a resource for workers,
responders, and residents across the country with a targeted focus on the population of United States
Department of Health and Human Services Public Health Regions 5, 6, and 8. The objective of each
training course is (1) to reduce work-related harm and, therefore, is part of the Hazardous Waste Worker
Training Program, HWWTP, or (2) to improve disaster preparedness and response and, therefore, is part
of the HazMat Disaster Preparedness Training Program, HDPTP. Building on past successes and using
evidence-based techniques to identify high-risk industries and communities, the Consortium projects an
annual delivery of approximately 361 courses to reach 25,000 workers and residents for an impressive
impact of almost 350,000 hours of training. The public health impact of the P2R Consortium is a
knowledgeable workforce and community with the skills and confidence to recognize and mitigate
hazards, thereby protecting health and well-being. Finally, as in the past, the P2R Consortium places
special emphasis on building the capacity of vulnerable communities to respond to environmental and
work-related threats.

Public health relevance
PROJECT NARRATIVE: OVERALL The Prevention, Preparedness, and Response (P2R) Consortium is relevant to public health because it will deliver practical health and safety training to workers and communities. This consortium focuses on teaching workers to recognize and mitigate hazards. It places special emphasis on training workers to protect themselves and their families and build their community’s capacity to respond to environmental and work-related threats.